Advancing Indigenous Cancer Health Equity through a Community-Centered Framework

This application is a resubmission in response to the Funding Opportunity Announcement (FOA) identified as
PAR-21-271.
PROJECT SUMMARY
In the US, cancer disproportionately affects many racial/ethnic minority communities, defining significant
cancer health disparities (CHDs). Across all racial/ethnic groups, American Indians and Alaskan Natives (AIANs)
experience one of the most substantial disparities with the highest comorbidity rates and lowest 5-year survival
rates for all major cancer types. CHDs are driven by a combination of biological and social determinants of
health, but actionable knowledge of both elements remains severely limited for AIANs. In this K99 proposal, I
will address two critical problems that have perpetuated CHDs among American Indians/Alaskan Natives
(AIANs): underrepresentation in precision medicine that limits discovery translation and race-level trends for
outcomes and SDOH that conceal community diversity critical to effective implementation. Neither issue can be
successfully addressed without the involvement and voices of Native communities, who have long been
subjected to extractive research practices with little to no return on community health. This proposal centers
Native communities living within the UCD Comprehensive Cancer Center catchment area (UCDCCC-CA) in a
community-based participatory research (CBPR) framework to develop guidelines for appropriate Native
community engagement for biomedical research while assessing community-level biological and social
determinants of cancer health and care access. In Aim 1, I will utilize whole exome sequencing data from 300
Hispanic/Latino (HL) gastric cancer samples to identify somatic alterations that are associated with Indigenous
American (IA) genetic ancestry at both global and local ancestry levels. These may be applicable to AIANs who
also share high IA ancestry. Associated loci will be functionally validated in HL patient-derived organoid models
in the R00 phase. In Aim 2, I will administer a validated survey and conducted focus groups interviews to identify
key factors that contribute to individual decision-making for participation and biospecimen donation in cancer
research among AIANs. In the R00 phase, I will work with UCDCCC-CA Native community stakeholders and my
Native community advisory board to translate these findings into Native community engagement guidelines for
research. In Aim 3, I will utilize cancer risk and health behavior data from the Aim 2 survey and cancer outcomes
and sociodemographic data from the California Cancer Registry to elucidate community-level social determinant
of health that drive UCDCCC-CA Native community cancer outcomes. In the R00 phase, I will use these findings
to identify areas of intervention in collaboration with community and Native-focused health clinic partners to
improve Native community cancer health. This proposal fulfills the mission of the National Institute for Minority
Health and Health Disparities to understand and reduce health disparities. The results of this proposal will
increase understanding of biological vulnerabilities and social determinants of health that lead to greater cancer
incidence and mortality among AIANs, while creating the infrastructure to ethically engage Native communities
and increase their participation in cancer research.

Public health relevance
This application is a resubmission in response to the Funding Opportunity Announcement (FOA) identified as PAR-21-271. PROJECT NARRATIVE American Indians/Alaskan Natives (AIANs) experience significant health disparities for cancer, which are driven by both biological determinants, such as Indigenous American genetic ancestry, and social determinants of health, such as socioeconomic status and geographical distance from care facilities. This proposal aims to understand these drivers through the engagement of Native communities living within the UC Davis Comprehensive Cancer Center catchment area. The results of this proposal will provide critical knowledge for the development of more effective treatments and interventions to improve cancer health among AIANs while also creating the infrastructure to ethically engage Native communities for participation in cancer research.